Perceived Fairness and Biological Stress Reactivity

DESCRIPTION (provided by applicant): Beliefs about fairness are a clinically significant predictor of cardiovascular health. Fairness beliefs are fundamentally important to cardiovascular health through their capacity to impact biological stress processes. However, the extent to which specific kinds of fairness beliefs influence important biological stress pathways is largely unknown. Ultimately, these limitations have impeded the capacity of researchers to better understand how fairness is implicated in cardiovascular illness, and also to evaluate fairness-oriented cardiovascular interventions. The long-term goal of this research is to elucidate the role played by fairness in cardiovascular health, and to determine whether fairness is a common causal process linking such other risk factors as racism, low SES, and work stress to subsequent biological mediators of cardiovascular illness. The objective of this application is to experimentally elucidate relationships between specific measurements of fairness beliefs and multiple biological stress pathways. The central hypothesis of this application is that procedural and distributive fairness will independently and interdependently predict more adaptive biological stress reactivity. In addition, we expect that these relationships will be reflected in both trait dispositions and situational judgments of fairness, and also in multiple biological and disease relevant stress pathways. The specific aims are to 1) measure the unique and interactive contributions of distributive (favorable outcomes) and procedural (treatment by others) fairness on biological stress reactivity;2) measure the unique and interactive contributions of dispositional (trait) and situationally induced (state) fairness on biological stress reactivity;3) measure relationships between fairness beliefs and important biological stress pathways, including markers of hemodynamic reactivity, HPA axis arousal, and pro-inflammatory processes. The proposed research will administer a modified version of a well established and laboratory-based stress induction paradigm. In doing so, this research will experimentally evaluate associations between specific kinds of fairness beliefs and multiple biological stress pathways. The public health implication of the project is significant. Namely, the proposed research will provide an important step towards defining disease relevant models, and for targeting and evaluating psychosocial interventions. PUBLIC HEALTH RELEVANCE: Beliefs about fairness predict both stress reactivity and incidence of cardiovascular illness. The proposed research will use experimental methodologies to assess independent and interdependent effects of multiple kinds of fairness beliefs on biological stress processes. The proposed research will carry important public health implications by elucidating the role of unique sources of fairness beliefs in important stress pathways, and by suggesting causal links between fairness and cardiovascular health.

Public health relevance
7. Project Narrative Beliefs about fairness predict both stress reactivity and incidence of cardiovascular illness. The proposed research will use experimental methodologies to assess independent and interdependent effects of multiple kinds of fairness beliefs on biological stress processes. The proposed research will carry important public health implications by elucidating the role of unique sources of fairness beliefs in important stress pathways, and by suggesting causal links between fairness and cardiovascular health.